Scaffolds with high oxygen content for mineralization

ABSTRACT
Each year more than 3 million craniofacial injuries occur in the US as a result of trauma, combat-associated
lesions, tumor removal, congenital abnormalities, and aging. Although some of these conditions can be
addressed by using the patient’s own tissues grafted from another site, this approach leaves the patients
susceptible to infections and creates additional trauma. Currently available methods for treatment and restoration
of craniofacial defects have limitations with the availability of autografts, immune rejection, high cost, inadequate
implant characteristics (oxygen content, mechanical properties, porosity, biocompatibility, degradation, infection
risks), and lack of vascularization. Bone repair is crucial to restore patient functionality post-injury. Scaffolds that
are easy-to-handle, inexpensive, biodegradable, bioactive, and non-immunogenic with adequate porosity and
oxygen content as well as proper mechanical strength are highly sought after for repairing craniofacial defects.
The choice of the implant material is of critical importance to facilitate recovery of the injured patients. Recently
we developed highly porous scaffolds composed of naturally derived polymers and oxygen-generating
components. When combined with cell sources that are compatible with the host, these scaffolds can enhance
craniofacial tissue healing. We propose to use materials that are easily accessible, porous, tunable, degradable,
and biocompatible. We aim to fabricate hybrid hydrogels that are composed of oxygen-generating depots and
gelatin, characterize their physical, chemical, and biological properties as well as studying differentiation of cells
and vascularization in these composites. Our preliminary findings suggest that the proposed novel composite
hydrogels exhibit significantly improved mechanical properties and indicate a favorable in vivo response by
subcutaneous implantation in a rat model as well as full regeneration of critical sized cranial defects. In Aim 1,
we will synthesize and characterize oxygen-generating biomaterials with optimized performance and
characterize them. In Aim 2, we will assess how the oxygen-generating depots affect cell differentiation and
osteogenesis, and develop a vascularized osteogenic model as well as evaluating the functionality of these
constructs. In Aim 3, we will implant these composite biomaterials into critical size calvarial defects in vivo to
induce bone regeneration. We expect that the integration of oxygen-generating depots into photocrosslinkable
hydrogels will result in a material with improved mechanical properties and will promote cell growth,
differentiation, biomineralization, and vascularization. These composite biomaterials will be suitable for repair or
regeneration of craniomaxillofacial tissues. Because oxygen-generating scaffolds will have outstanding
tunability, they are expected to be also useful for applications in other tissues such as cartilage. Porous scaffolds
with high oxygen content are highly promising materials for creating functional vascularized tissues, and are
expected to improve craniomaxillofacial tissue repair and human health.

Public health relevance
NARRATIVE Currently available synthetic grafts are unable to mimic the characteristics of vascularized bone or readily induce biomineralization. The proposed work develops oxygen-generating protein-based hydrogels to create highly vascularized and mineralized 3D constructs. These novel hybrid biomaterials represent a first step towards creating functional vascularized bone in physiologically-relevant sizes, therefore, they will improve regeneration of mineralized craniofacial tissues and enhance human health.